Supplement: Accurate Molecular Decision Making during Protein Biogenesis

The scope of the research is defined by my current research proposal and is copied
below.
Project Summary for R35 GM136321 (2020-2025)
Accurate protein biogenesis is essential for the generation and maintenance of a functional
proteome. Our long term goal is to understand the molecular mechanisms by which diverse
protein biogenesis pathways in the cell accurately select nascent protein substrates and ensure
their correct folding, localization, and maturation. Two major components define our research
program in this grant cycle. First, we will use a combination of biochemical, biophysical, and in
vivo experiments to decipher the mechanisms by which nascent proteins emerging from the
ribosome are selected and processed by ribosome-associated protein biogenesis factors
(RPBs) in the crowded space of the ribosome tunnel exit. These studies will include a new co-
translational membrane protein targeting pathway mediated by SecA, enzymes mediating N-
terminal methionine excision on nascent proteins in bacteria, and co-translational protein
targeting mediated by SRP in the mammalian system. In addition to studying the biochemical
and biophysical mechanisms of the individual protein biogenesis pathways, we will also
elucidate how each of these factors coordinates with other RPBs in space and time during
ongoing translation, and how this coordination reshapes the efficiency and fidelity of the
individual pathways. Second, we will decipher the mechanisms by which aggregation-prone
membrane proteins are effectively protected and facilely guided to the target membrane during
their post-translational targeting. These studies will use two membrane protein biogenesis
pathways as models: (i) an ATP-independent chaperone cpSRP43, which allows us to decipher,
at biophysical resolution, the molecular mechanisms by which a small chaperone effectively
protects multi-pass membrane protein clients and achieves spatiotemporal regulation of its
client interactions in the absence of ATPase cycles or cochaperones; (ii) the guided-entry of tail-
anchored proteins (GET) pathway, which provides an excellent system to decipher how a multi-
component Hsp70- cochaperone cascade protects, funnels, and triages nascent membrane
proteins during their targeted delivery. Investigation of the GET pathway will also allow us to
gain insights into the design and organizational principles of analogous chaperone networks in
the cell. The proposed experiments will not only generate high resolution understandings of the
individual protein biogenesis pathways, but also establish valuable tools, reagents to explore the
action of other protein biogenesis machineries. Most importantly, this research will generate
important conceptual frameworks to understand how nascent proteins are accurately selected
into their appropriate biogenesis pathways in the crowded cytosolic environment.

Public health relevance
Project Narrative Accurate protein biogenesis is a pre-requisite for the generation and maintenance of a functional proteome, and is critical for preventing the onset of numerous diseases rooted in defective protein homeostasis. The proposed studies will advance our knowledge of the molecular and cellular mechanisms that ensure protein homeostasis within the cell, and contribute to the general understanding of physiology and pathology of eukaryotic cells at a fundamental level.